Genetic basis for TLR7-independent antiretroviral antibody responses

PROJECT SUMMARY/ABSTRACT
The goal of this application is to identify novel mechanisms by which antiretroviral antibody responses are
generated. Retroviruses are highly successful pathogens, able to subvert or evade immune responses in most
infected individuals. In some unique cases, the detection of viral infection by the innate immune system results
in the induction of an adaptive immune response able to control viral infection and prevent the development of
disease. This ability to control retroviral replication is most often driven by the specific genetic make-up of the
host. However, investigation of the genetic and immunologic basis for these responses in humans is extremely
difficult; therefore, animal models of retroviral infection are required for the dissection of the requirements for
protective immune responses. To this end, murine models of retroviral infection have provided essential insights
into understanding the molecular mechanisms of anti-retroviral immune responses. In particular, inbred strains
capable of mounting neutralizing antibody responses provide the opportunity to dissect the signaling pathways
underlying these responses. The canonical pathway for antiviral antibody production in mice involves detection
of retroviral RNA in the endosome by the innate immune receptor Toll-like receptor 7 (TLR7). TLR7/MyD88
signaling is followed by activation of CD4+ T cells, and IFNγ-mediated stimulation of Ab production by virus-
specific B cells. This is the predominant pathway for the generation of neutralizing responses to a variety of RNA
virus infections, including retroviral infections. We recently identified that some inbred mice inherit an alternative,
TLR7-independent pathway to produce retrovirus-neutralizing antibodies. The studies proposed in this
application will elucidate (1) the genetic mechanisms underlying this unique pathway, and (2) the alternative
innate immune mechanism that stimulates this alternative pathway. The knowledge gained by this investigation
will uncover the basis for a previously unappreciated pathway for antibody production in response to viral
infection. Such insight could greatly aid the development of new animal models of human disease and novel
therapeutic intervention.

Public health relevance
PROJECT NARRATIVE The generation of virus-neutralizing antibodies is essential for recovery from infection and for the development of protective vaccines. Stimulation of antibody production requires detection of the infection and activation of downstream signaling networks. This project will reveal the genetic basis for a previously unknown pathway for the detection of retroviral infection and stimulation of anti-viral antibody production.